CORE--TISSUE PROCUREMENT FACILITY

Description: (Applicant's Description) The goal of the Tissue Procurement Facility (TPF) is to be a clearinghouse for the collection and distribution of human tissues to scientists involved in cancer research. Implicit within this primary goal are five related objectives: (a) prompt collection of human cancer tissue from multiple clinical service areas in the medical center, (b) preservation and storage of human cancer tissue for use in genetic, molecular, histochemical, and tissue culture uses, (c) distribution of tumor tissues and related services for research use, (d) quality assurance, and (e) assimilation and distribution of clinical, cellular, and molecular data regarding each tissue collected. This shared resource aids investigators by providing services that are more timely, more comprehensive, and more efficient than individual investigators can generally provide for themselves. This has been accomplished by developing and maintaining channels for tissue collection from multiple sources, developing reliable protocols for tissue preservation, and distributing lists of available tissues quarterly to cancer center researchers. Since the inception of this facility, there has been steady increase in use by investigators. We propose now to expand the facility's role to facilitate preparation of DNA from tumor and normal tissue specimens for studies of genetic susceptibility and other aspects of cancer genetics.